WATER INDUCED SURFACE CHANGES IN SILICONE ELASTOMERS

ESCA is being utilized to detect and characterize degradation taking placeduring hot water treatment of silicone elastomers.The relation between temperature and rate of degradation is sought.